BIOMEDICAL DATA TRANSLATOR USER INTERFACE DEVELOPMENT

As a result of recent scientific advances, a tremendous amount of data is available from biomedical research and clinical interactions with patients, health records, clinical trials and adverse event reports that could be useful for understanding health and disease and for developing and identifying treatments for diseases. Ideally, these data would be mined collectively to provide insights into the relationship between molecular and cellular processes (the targets of rational drug design) and the signs and symptoms of diseases. Currently, these very rich yet different data sources are housed in various locations, often in forms that are not compatible or interoperable with each other. All of these factors limit the ability to get more treatments to all people more quickly.

To address these problems, NCATS launched the Biomedical Data Translator program, called “Translator” for short. This multiyear, iterative effort will culminate in the development of a comprehensive, relational, N-dimensional Biomedical Data Translator that integrates multiple types of existing data sources, including objective signs and symptoms of disease, drug effects and intervening types of biological data relevant to understanding pathophysiology.